Physiological-based Pharmacokinetics Approach to Determine the Extent of Drug Exposure of Antiseizure Medications During Pregnancy and Breastfeeding

ABSTRACT
Antiseizure medications are one of the most commonly prescribed teratogens. In pregnant women with
epilepsy, continuation of antiseizure medications and dose increases are often necessary to prevent
seizure worsening, but need to be balanced against the fetal risks of in utero exposure, such as congenital
malformations and adverse neurodevelopmental outcomes. Additionally, breastfeeding introduces another
route of drug exposure to the infant and can affect child development. Although measurement of drug
concentration in plasma is thought to reflect drug concentrations at the site of action in the mother, it is more
difficult to translate the overall exposure to the fetus or determine the full extent of the exposure to the child
through breastfeeding. Physiological-based pharmacokinetic (PBPK) methods will be used to advance a
precision medicine approach to characterize drug concentration-time profiles at the tissue level allowing
evaluation of target doses needed to achieve optimal drug exposure in women with epilepsy, taking into
account drug exposure to the fetus during pregnancy and to the breastfeeding infant. Information from both
basic science and clinical studies will be used to develop, evaluate, and validate PBPK models. This grant will
use previously collected data and new measures from existing samples in the clinical study MONEAD, animal
data, in vitro studies, and a new external validation cohort with sampling at critical timepoints (not previously
obtained) to determine the mechanistic basis of alterations in antiseizure medication concentrations during
pregnancy and lactation. These data can then be combined with outcome data in other clinical studies to
expand our knowledge of drug response and safety in women and children during two very vulnerable times,
pregnancy and lactation.

Public health relevance
NARRATIVE Seizure risk during pregnancy increases as drug clearance changes throughout pregnancy, often resulting in the need for increased dosing of anti-seizure medication in pregnant women; however, increased dosing also increases the risk of established negative outcomes to the fetus. This grant will use previously collected data and new measures from existing samples from the clinical study Maternal Outcomes and Neurodevelopmental Effects of Anti-Epileptic Drugs (MONEAD), animal data, in vitro studies, and an external validation cohort with sampling at new critical timepoints to determine the mechanistic basis of alterations in antiseizure medication concentrations during pregnancy and lactation. The outcomes of this effort will enable physiological-based modeling and approaches to optimize antiseizure medication dosing and decrease seizure risk during pregnancy while limiting unnecessary exposure (risk) to the fetus and breastfeeding child.